Combining antigen-specific vaccination with radiopharmaceutical therapy (RPT) to enhance anti-tumor immunity and efficacy

PROJECT SUMMARY
Prostate cancer is the second leading cause of cancer-related death among men in the U.S. With a
median life expectancy of less than 3 years for patients with metastatic castration-resistant prostate cancer,
additional life prolonging therapies are needed. Currently approved therapies for this late-stage prostate cancer
include immunotherapy and radiopharmaceutical therapy (RPT).
Therapeutic cancer vaccines activate tumor-specific CD8+ T cells to infiltrate and kill tumor cells. Yet,
tumors have evolved resistance mechanisms against the vaccine, in particular, the recruitment of
immunosuppressive CD4+ regulatory cells (Tregs) and myeloid-derived suppressor cells (MDSCs). A recently
approved RPT targeting prostate-specific membrane antigen (PSMA) can deliver radiation specifically to prostate
cancer cells (177Lu-PSMA-617, also known as Pluvicto). As the radioisotope decays, additional tumor-infiltrating
cells, such as Tregs and MDSCs, are irradiated as well. The physical properties of the radioisotope can largely
affect the magnitude of radiation-induced cell killing as well as type I interferon in surviving cells. Therefore,
selecting radioisotopes that effectively deplete Tregs and MDSCs while enhancing CD8+ T cells recruitment,
might be advantageous in combination with targeted immunotherapy. We hypothesize the initial priming of
tumor-specific CD8+ T cells using an anti-tumor vaccine, followed by depletion of Tregs and MDSCs by
RPT, will enhance the infiltration of tumor-specific CD8+ T cells with memory phenotypes, enhancing
anti-tumor efficacy.
We have recently generated a novel immunocompetent transgenic mouse strain tolerant of human PSMA
(hPSMA) in which hPSMA is expressed in the native mouse prostate. These mice will be implanted with
syngeneic murine prostate cancer cell lines expressing human PSMA (TRAMP-C1-hPSMA or RM-1-hPSMA).
Aim 1 will evaluate the depletion and functional suppression of tumor-infiltrating Tregs and MDSCs induced by
the radionuclides of varying therapeutic emissions (α-emitting Actinium-225, β/Auger electron emitting Terbium-
161, and β-emitting Lutetium-177) linked to a PSMA-targeting moiety. Aim 2 will determine the anti-tumor efficacy
of combining tumor-specific vaccination with PSMA-targeting RPT and characterize tumor-infiltrating CD8+ T
cells. The immunomodulatory effects of PSMA-targeting RPT have been mostly unexplored due to the lack of
an appropriate preclinical model. Our novel mouse model provides the opportunity to study the timing and
mechanism of combining PSMA-targeting RPT with T-cell activating therapy. The translatable findings from this
proposed work have the potential to be developed as a novel therapeutic approach to prolong the lives of patients
with prostate cancer.

Public health relevance
PROJECT NARRATIVE Novel therapeutic approaches to the treatment of advanced prostate cancer are needed due to the limited efficacy of current treatments. Combining tumor-specific vaccination to activate CD8+ T cells and radiopharmaceutical therapy to deplete tumor-infiltrating suppressive populations may be a promising approach to enhance anti-tumor immunity and efficacy. This proposal aims to target immunoresistance mechanisms of prostate cancer using radiopharmaceutical therapy, which will be critical for determining the selection and timing with immunotherapies, potentially prolonging the lives of patients.